Small molecules for perturbing iron homeostasis in bacterial biofilms

ABSTRACT
Chronic wound care is especially complicated by the formation of bacterial biofilms, commonly by Pseudomonas
aeruginosa, Acinetobacter baumannii and Staphylococcus aureus. Biofilms are recalcitrant to antibiotic therapy,
which is an important reason why chronic wound infections are so difficult to eradicate. There is a significant
need to discover new strategies to combat biofilms. Bacterial iron homeostasis is a suitable novel target for
developing anti-infectives because the host makes essential iron scarce to invading pathogens. Bacteria have
evolved mechanisms to “steal” iron from their host, but these depend on well-regulated iron homeostasis. To
disrupt bacterial iron homeostasis, we are targeting the iron storage protein BfrB and its physiological partner
protein, Bfd, which are unique to bacteria. Our work has shown that BfrB regulates cytosolic iron concentrations
by (a) oxidizing Fe2+ and storing up to ~3,000 Fe3+ ions in its internal cavity, and (b) forming a complex with Bfd
to reduce Fe3+ in the internal cavity of BfrB and release Fe2+ to the cytosol for its incorporation in metabolism.
Blocking the BfrB-Bfd complex in P. aeruginosa cells by deletion of the bfd gene perturbs iron homeostasis by
triggering an irreversible accumulation of Fe3+ in BfrB and simultaneous cytosolic iron depletion, which leads to
impaired biofilm maintenance and biofilm cell death. Our work also led to the discovery of proof-of-concept
inhibitors of the BfrB-Bfd complex, which bind BfrB at the Bfd binding site, inhibit iron mobilization, and elicit
biofilm cell death. The objectives of this application are to improve the proof-of-concept molecules into lead
molecules, evaluate their antibacterial and antibiofilm effectiveness, and evaluate their potential drug suitability.
Our interdisciplinary team includes expertise in chemical and structural biology of bacterial iron homeostasis
(Rivera), organic synthesis and reaction mechanisms (Bunce), pharmaceutical industry research and
development of anti-infectives (Reitz), X-ray crystallography in drug discovery (Lovell), microbial genetics
(Chandler), and animal model of infection (Morici). The specific aims are: 1) Evolve proof-of-concept analogs
into potent inhibitors of the BfrB-Bfd complex. This work will follow a systematic, iterative strategy of medicinal
chemistry synthesis optimization that relies on crystal structures of inhibitor bound BfrB to design each new
generation of inhibitors. 2) Asses the antibacterial effectiveness of inhibitors of the BfrB-Bfd complex and
evaluate their potential drug suitability.

Public health relevance
PROJECT NARRATIVE Pseudomonas aeruginosa, one of the most problematic antibiotic-resistant Gram-negative pathogens, has a proclivity to form biofilms that are intrinsically tolerant to antibiotics, which is an important reason for the persistence of chronic (biofilm) infections. Our team has discovered proof-of-concept inhibitors of the BfrB-Bfd protein-protein complex which dysregulate bacterial iron metabolism and kill P. aeruginosa in biofilms. This project will improve the proof-of-concept molecules into lead molecules for inhibiting the BfrB-Bfd complex in Gram-negative bacteria.